Genetic and Molecular Analyses of Human LINE-1 Retrotransposition

Abstract
Long INterspersed Element-1 (LINE-1 or L1) transposable element derived sequences comprise
approximately 17% of human genomic DNA. Although the overwhelming majority of LINE-1s have been rendered
immobile by mutational processes over evolutionary time, an average human genome contains approximately
100 active LINE-1s that can mobilize to new genomic locations via an RNA intermediate by a process known as
retrotransposition. The retrotransposition of active LINE-1s in the germline, during early development, or in select
somatic cells continues to generate inter- and intra-individual genetic variation and can lead to sporadic cases
of human genetic diseases, including hemophilia A, hemophilia B, Duchenne muscular dystrophy, and certain
cancers. We posit that a mechanistic understanding of LINE-1 biology is essential to understand the forces that
contribute to human disease, human genetic variation, and human evolution. This proposal represents the third
competing renewal application of GM060518, and seeks ongoing support to continue our studies of LINE-1
biology. We will build upon our experience and knowledge in the field of mobile genetic elements, use insights
gained from studies of the mobility mechanisms of evolutionarily related retrotransposons, and employ a LINE-
1 cultured cell retrotransposition assay in conjunction with an integrated strategy that combines genetic,
molecular biological, biochemical, multi-omic, and computational approaches to answer cutting-edge questions
in LINE-1 biology. This proposal comprises two Aims, which build upon our extensive toolbox of reagents,
previous findings, and preliminary data. In Aim 1, we will elucidate mechanistic aspects of LINE-1
retrotransposition. In Aim 2, we will determine how host proteins act to facilitate or restrict LINE-1
retrotransposition. This project will benefit from a long-standing successful collaboration between the Moran and
Kidd laboratories at the University of Michigan and our outstanding research teams. The successful completion
of the above Specific Aims will increase our understanding how LINE-1s mobilize to new genomic locations, how
the host has evolved mechanisms to prevent unabated LINE-1 retrotransposition, and how LINE-1 has exploited
cellular proteins to aid in its retrotransposition. This knowledge also will provide insights into how LINE-1
retrotransposition contributes to human disease, human genetic variation, and human genome evolution.

Public health relevance
Narrative The average human genome contains ~100 active Long INterspersed Element-1 (LINE-1 or L1) sequences that can mobilize to new genomic locations by a process known as retrotransposition. L1 retrotransposition events in the germ line, during early development, or in somatic cells generate inter- and intra-individual genetic diversity and are implicated in a myriad of sporadic genetic diseases, including Hemophilia A, Duchenne muscular dystrophy, and certain cancers. The goal of this R01 proposal is to use a cultured cell retrotransposition assay in conjunction with an integrative strategy that involves genetic, molecular biological, biochemical, multi- omic, and computational approaches to: (i) elucidate how L1s move to new genomic locations; and (ii) determine how host factors act to restrict or facilitate L1 retrotransposition. This knowledge will provide insights into how L1 retrotransposition contributes to human disease, human genetic variation, and human genome evolution.